NETs: Protection or Harm in Neonatal Inflammation and Infection

We have successfully used our novel Neutrophil Extracellular Trap (NET)-Inhibitory Peptides (NIPs) to show that
in experimental models of neonatal sepsis NETs increase inflammatory injury and mortality. Neutrophils extrude
NETs, extracellular lattices of decondensed chromatin decorated with histones and antimicrobial proteins, to
protect against infection by trapping and killing microbes. NIPs, however, inhibit NETs, decrease inflammatory
injury, and increase survival in models of experimental sepsis whether used alone or in combination with
antimicrobial agents like meropenem. The receptor for NIPs and the cellular mediators of NIP-induced NET
inhibition remain unknown. This project will determine whether proteinase 3 (PR3), a serine protease present on
the outer membrane of a subset of unstimulated neutrophils, serves as that receptor and whether NIPs must
bind PR3 to inhibit NET formation.
Using NIPs as tools for discovery, we will evaluate PR3 as a novel endogenous regulatory checkpoint that limits
NET-mediated inflammatory tissue damage in sepsis. PR3 represents a novel NIP binding partner which
complexes CD177 and phospholipid scramblase 1 (PLSCR-1) on the neutrophil surface. CD177 activates the
Mac-1 integrin on neutrophils leading to reactive oxygen species generation and NET formation. PLSCR-1
mediates neutrophil apoptosis and facilitates membrane flipping in neutrophil lipid rafts. Using surrogate
neutrophils differentiated from human hematopoietic stem cells and CRISPR/cas9 gene editing, our preliminary
data show that NIP-mediated NET inhibition in neutrophils requires PR3 but NET formation does not. Further,
PR3 knockout mouse pups fail to respond to NIPs and show decreased survival compared to wild type NIP-
treated pups, suggesting that NIPs require PR3 to inhibit NET formation in vivo. Additional data show that NIP
binding to PR3 may alter CD177- and PLSCR-1-dependent effects on NET formation and neutrophil apoptosis.
This proposal outlines three specific aims that will provide novel insights into PR3’s role as an anti-inflammatory
mediator of NET inhibition by NIPs in neonatal sepsis. We will: 1) determine whether PR3 is a/the required
receptor of NIPs; 2) determine whether the PR3-complexed proteins CD177 and PLSCR-1 facilitate PR3-
dependent NIP-mediated NET inhibition and apoptosis, respectively; and 3) determine whether neutrophil PR3
expression protects or harms in neonatal sepsis. These studies will significantly advance the field by identifying
the receptor for NIPs on neutrophils, determining the downstream mechanistic effects of NIP binding to PR3,
and evaluating the importance of neutrophil PR3 expression in preclinical models of neonatal sepsis. Our
laboratory is uniquely poised to answer these innovative, translational, and mechanistic questions regarding
PR3 and NIPs in neonatal sepsis. As demonstrated during our initial award, the impact of these studies will
extend beyond neonatal sepsis to other inflammatory syndromes of prematurely born infants and adults, e.g.,
necrotizing enterocolitis, ischemic stroke, and COVID-19.

Public health relevance
Project Narrative This project will determine the role of neutrophil proteinase 3 (PR3) in mediating the Neutrophil Extracellular Trap (NET) inhibitory effects of NET-Inhibitory Peptides (NIPs) – novel inhibitors of NET formation that we discovered in human umbilical cord blood. NETs are DNA-based structures formed by neutrophils to trap and kill bacteria outside of the cell, but unregulated NET formation can kill mouse pups in models of neonatal overwhelming infection, and use of NIPs in these models rescues survival. In these studies, we will uncover mechanisms through which NIPs inhibit NET formation, establish PR3 as a required neutrophil receptor for NIP- mediated NET inhibition, and determine survival and illness severity in infected neonatal mice lacking PR3 expression.